Mechanisms of Sonic Hedgehog Signal Transduction

PROJECT SUMMARY
The evolutionarily conserved Sonic Hedgehog (SHH) signaling pathway governs tissue morphogenesis during
development and contributes to tissue homeostasis in adults. Alteration of pathway activity drives
developmental disorders including Holoprosencephaly (HPE), Pallister-Hall Syndrome and Basal Cell Nevus
syndrome. Inappropriate activation of signaling post-developmentally is frequently associated with cancer,
being causative in basal cell carcinoma and medulloblastoma, and implicated as a survival factor in a range of
additional tumor types. As such, there is significant interest and therapeutic potential in defining the
mechanisms governing SHH pathway activity. My laboratory’s long-term goal is to define the regulatory
processes governing SHH pathway activity during development and use this knowledge to identify
opportunities for targeting inappropriate SHH signaling in disease. Over the next 5 years, we will continue to
work toward this goal by interrogating and defining the molecular mechanisms controlling pivotal regulatory
steps of the SHH signal transduction cascade. We are focused on elucidating 1) how SHH ligand release and
transport are controlled to establish a morphogen gradient, 2) how SMO activation is controlled and how it
coordinates its activity with other G protein coupled receptors at the primary cilium, and 3) how GLI
transcriptional activator induction and destabilization are coordinated to assure an appropriate transcriptional
response.

Public health relevance
Project Narrative (Relevance Statement): The Sonic Hedgehog (SHH) signal transduction pathway is an essential regulator of organ and tissue development that when corrupted leads to developmental disorders and cancers. The goals of my research are to define the mechanisms by which SHH is deployed from its site of synthesis to reach cellular targets with temporal and spatial precision for induction of specific responses in receiving cells. Knowledge obtained from the proposed studies will enhance our understanding of the mechanisms controlling an essential developmental process and may reveal novel methods of targeting the SHH pathway in disease.